Mechanisms of experience-dependent odor categorization in the olfactory cortex

Project Summary / Abstract
Olfaction is the dominant sense used by many animals to detect cues in the environment and generate
appropriate responses, such as finding food and avoiding predators. To make sense of a complex, dynamic
sensory environment, the brain uses of categorization, organizing related sensory representations into
perceptual classes. In the case of olfaction, humans and other animals can group chemically distinct stimuli like
lemon and lime into perceptual odor categories like citrus. It is unclear, however, how these categories are
represented in the brain, or how they adapt with learning and experience. In the mammalian brain, relationships
between odors are represented in the olfactory (piriform, PCx) cortex by correlated patterns of neural activity.
The similarity of these cortical odor representations predicts odors’ perceptual similarity. Cortical relationships
do not straightforwardly reflect chemical similarity, however. Rather, PCx re-organizes odor relationships relative
to those in the sensory periphery and clusters representations of related odors. Odor responses in PCx have
also been shown to be modulated by contextual factors like tasks and rewards, and preliminary work from the
Datta lab suggests that PCx odor relationships may be modified by passive odor experience. Despite these
insights, it is unclear how the structure of cortical odor space evolves over time with learning and experience. I
hypothesize that relationships between odor representations in PCx are reorganized through experience
to reflect associations between odors in the world and drive behaviorally relevant perceptual
categorization. In Aim 1, I will explore how temporal odor associations influence neural and perceptual odor
similarity. I will combine long-term electrophysiological recordings in PCx with behavioral assays of perception
to examine whether odors which are repeatedly experienced together are represented more similarly in PCx and
perceived more similarly. I will also utilize targeted genetic perturbations to examine the role of intracortical
associative circuit plasticity in these changes. In Aim 2, I will investigate contextual odor associations to ask
whether odors associated with the same context in an odor-visual virtual reality environment are represented
and perceived more similarly. Together, these experiments will reveal how learning and experience shape odor
representations in the mammalian olfactory cortex and provide broader insights the mechanisms of flexible
sensory processing.

Public health relevance
Project Narrative Humans and other animals use olfaction, the sense of smell, to perform a number of essential behaviors, including detecting food and avoiding predators. This work aims to understand how the piriform cortex, a brain region important for processing odor information, represents relationships between odors, and how these relationships may change depending on an animal's experience and learning. Results from this study will contribute to a broader understanding of how learning shapes sensory perception, and offers potential benefits for understanding and treating olfactory dysfunction observed in numerous neurological disorders.